The Washington University Center for Diabetes Translation Research

PROJECT SUMMARY/ABSTRACT – Overview
This is an application for the continuation of the Washington University Center for Diabetes Translation
Research (WU-CDTR). The Center is guided by our strategic vision in which a health equity lens is the
foundation for transformative diabetes research translated into action and impact. This equity-driven vision
informs our Center mission to be the nexus for transdisciplinary team science in advancing the conduct of the
next generation of diabetes translation research. Our goal is to advance a rigorous, scientific evidence base to
inform the dissemination, implementation, and sustainability of efficacious interventions for populations at risk
for diabetes disparities. The WU-CDTR is the intellectual home to an outstanding network of investigators who
conduct research on the root causes of diabetes inequities, informed by social determinants of health and
organized around five thematic areas: biobehavioral discovery; living and working conditions; health care
context; health information and technology environment; and community, policy and systems research. The
research base consists of 87 investigators (66 Full Members and 21 Associate Members) from within
Washington University, and 21 different universities with members affiliated through our Regional and National
Resource Cores (Department of Health Management and Informatics at the University of Missouri in Columbia;
and the Council on Black Health at Drexel University in Pennsylvania, respectively). Our research base is
defined by established (69%) and new diabetes investigators (31%), as well as those from underrepresented
minority populations (38%); members work in collaboration with a network of multi-sectoral partners (N=73)
including healthcare and non-health care organizations. From 2016 to present, WU-CDTR investigators were
awarded $243.2 million in total direct costs and $66.8 million in annual direct costs. This includes 86 current
and ongoing Center supported grants generating $173.3 million in total direct costs and $40.7 million in annual
direct costs; 65% of WU-CDTR Full Members have NIH funding, and 80% of total grant support is from federal
sources. The WU-CDTR is organized around five novel Translational Research Cores, led by national experts
in their respective fields. They include cores on: Dissemination and Implementation in Diabetes Research;
Policy and Systems Science Analysis; Health Communication and Social Needs; Health Informatics in
Diabetes Research (Regional Resource); and Solutions to Diabetes in Black Americans (National Resource).
We also sponsor a very successful Pilot and Feasibility Program focused on early stage and under-
represented minority investigators and a vibrant Enrichment Program, which enhances education and
awareness of diabetes translation research. The WU-CDTR enhances efficiency, productivity, and rapid
research translation across a national network of investigators while fostering collaborations to achieve
diabetes health equity.

Public health relevance
PROJECT NARRATIVE – Overview The Washington University Center for Diabetes Translation Research (WU-CDTR) supports research on the root causes of diabetes inequities informed by the social determinants of health. The Center includes five novel Translational Research Cores: Dissemination and Implementation in Diabetes Research; Policy and Systems Science Analysis; Health Communication and Social Needs; Health Informatics in Diabetes Research (Regional Resource); and Solutions to Diabetes in Black Americans (National Resource); and sponsors a Pilot and Feasibility Program and an Enrichment Program. The WU-CDTR enhances efficiency, productivity, and rapid research translation across a national network of investigators while fostering collaborations to achieve diabetes health equity.